Mentoring the next generation of trainees in patient-oriented, community engaged research in obesity and health equity

PROJECT SUMMARY/ABSTRACT
Over 42% of adults have obesity, which is more prevalent in various populations. While even modest (3-5%) weight loss improves this risk, we and others have found that vulnerable populations lose less weight with bariatric surgery. To address discrepancies in obesity outcomes and promote opportunities for significant health improvements in all populations (i.e., health equity), the focus of my patient-oriented research has been to develop and test weight management interventions in real-world patient populations. I am currently PI on 4 behavioral clinical trials funded through the NIH and Veterans affairs and one longitudinal bariatric surgery cohort study. These studies, with approximately 1700 patients enrolled thus far, have supported the training of several students, post-doctoral fellows and junior faculty.
I have been passionate about mentoring trainees and exceptional scholars from all backgrounds. NYU Langone Health provides a rich training environment for mentees at all levels to advance their research careers. This K24 award will provide me with additional resources and protected time to increase the impact of my trainees’ and my research. With collaboration and guidance from my K24 Advisory Committee and Community Advisory Board (CAB) members, the K24 will support the following Short-Term Career Objectives 1) To be a primary mentor for 1-2 additional junior faculty or fellows per year; 2) To improve my skills in mentoring trainees; 3) To increase my expertise and mentorship in social determinants of health (SDOH) and community engagement; 4) To develop leadership skills to expand the impact of my mentoring; and 5) To obtain 2 additional R01-level or higher grants to test and implement interventions to improve obesity outcomes. Through formal coursework, conferences, and hands-on experiential training, I will enhance my skills and expertise in leadership and mentorship in social determinants of health and community-engaged research. The K24 advisory committee, consisting of senior leaders and collaborators in these areas, will advise on my research and training aims and will review a yearly formal evaluation of my mentoring.
My mentees and I are interested in how individual and neighborhood level markers impact weight management outcomes in vulnerable populations. For our research aims, we will use existing datasets (n=768) participants in health coaching weight management intervention studies and 207 participants in a bariatric surgery cohort study to evaluate the impact of neighborhood- and individual- level SDOH on weight management outcomes. We will engage relevant patient and community stakeholders to collaborate on all aspects of the research. The research aims were developed through extensive discussions with each of my current mentees to enhance their training, support their individual research and improve the care of vulnerable patients with obesity.

Public health relevance
PROJECT NARRATIVE The protected time and resources provided through this K24 mid-career mentoring award will enhance my ability to recruit and train patient-oriented researchers focused on addressing obesity and improving care of vulnerable patients with obesity. The research aims, focused on evaluating the impact of social determinants of health on weight management, will provide additional opportunities for me and my trainees to obtain additional expertise in social determinants of health and community-engaged research. With guidance from my K24 Advisory Committee and hands-on training, I will enhance my skills in recruiting and mentoring trainees from all backgrounds to enhance their training, support their individual research, and improve the care of vulnerable patients with obesity.